ARDVARC- Advancing Rare Disorders: Vascular mAlformations Research Network with CaNVAS: Pilot Core

ARDVARC Pilot/Feasibility Governance Core: Project Summary
Rapid exploration of the molecular alterations underpinning of complex vascular malformations (cVM) has
identified potential therapeutic targets for these patients. However, the current portfolio of genotype-driven
clinical trials harnessing these advancements has lagged behind scientific discovery and remains extremely
limited. Furthermore, there is unclear prioritization of treatment modalities, therapeutic agents, quantitative
imaging methods, and response criteria. In particular, PIK3CA-related overgrowth spectrum (PROS) with VMs,
complex lymphatic anomalies (CLA), and extra-cranial arteriovenous malformations (eAVM) remain specific
diseases with significant unmet needs. The overall aim of this Rare Disease Clinical Research Consortium
(RDCRC), ARDVARC, is to construct an interdisciplinary research team (patient advocacy groups, clinical,
translational, basic, and health services scientists) with the RDCRN to enhance clinical trial readiness for
patients with cVM. This Pilot/Feasibility Governance Core will serve two essential functions to advance clinical
research and clinical trial readiness for cVM. First, this core will establish a standard blueprint for evaluation
and prioritization of novel Treatments and Assessments that focus on cVM. Second, this core will provide pilot
funding to support and encourage preclinical, clinical, and logistical studies that address limitations or
roadblocks preventing the clinical implementation of novel Treatments and Assessments. With the separate
Steering and Grants Committees we will develop processes for each of these functions that are rigorous,
transparent, and fair with evaluation of the efficiency and efficacy of these functions for continual process
improvement. The ARDVARC mission will be further supported by incorporating clinical trial-embedded
correlative studies, prioritizing access to precious biologic patient samples with annotated clinical correlates,
providing access/exposure to RDCRC/RDCRN and advocacy group resources, integrating junior investigators
into Core activities, and fostering collaboration both within the RDCRC and beyond. Our team has rich
expertise in vascular malformations, clinical and translational research, and team management uniquely suiting
them to lead this Pilot/Feasibility Core. Together the Pilot/Feasibility Core aims will not only accelerate
research in rare cVM but also unify efforts to advance treatments and assessment methods for the unmet
needs of this severely impacted rare disease population.